Administrative Core

PROJECT SUMMARY / ABSTRACT
Administrative Core (Crotty)
The purpose of Core A is to provide administrative, fiscal, and information technology (IT) support to all
projects within the P01. The Core will be based at LJI, the P01’s home institution, but will be utilized equally by
all projects. The Administrative Core provides a central focus for the program. The Administrative Core of the
P01 will facilitate interactions between the projects and with the National Institutes of Health. The goal of this
core is to provide programmatic direction and promote interaction between the investigators. It will be the
responsibility of the Administrative Core to assure access to core facilities by all Projects funded by this
application.